ATP Binding Cassette (ABC) Transporters in Fungal Drug Tolerance

Members of the Multi-drug Resistance Protein (MRP) family of ATP Binding Cassette (ABC)
transporters contribute to drug tolerance in major fungal pathogens, including Candida species, in 2 main
ways: 1) they detoxify the cell of cytotoxic molecules such as antifungal drugs and electrophiles/oxidants
by sequestering them in the vacuole, and 2) they cause complex morphological changes such as hyphal
extension and biofilm formation linked to drug tolerance. Because of their role in these survival
mechanisms, MRP family members are often required for infection and are tightly regulated by the cell.
The overall objective of this proposal is to bridge gaps in our understanding of how these transporters
contribute to the increasing threat of drug resistance in fungal pathogens. Mechanistic models that
explain this resistance are especially lacking, limiting antifungal treatment efficacy. The long-term goal is
to understand how anti-fungal treatments fail. To this end, we specifically focus on early stage anti-stress
responses through enzymatic, structural, and cellular investigations of two prominent vacuolar MRP
transporters: Ycf1 and Mlt1. Our rationale is that these insights will provide a foundation for exploiting
unique aspects of transporter architecture in order to generate more effective therapies that overcome
drug tolerance in fungal infections.
Our preliminary work identifies key features of MRP family transporter regulation during fungal stress
responses. These are complex substrate binding sites and the regulation of different states of an
intrinsically disordered region called the Regulatory-domain (R- domain) by phosphorylation. Our central
hypothesis is that MRP transporters are governed by domain insertions outside of the conserved
transporter fold that regulate multi-segmented substrate binding sites. Our specific aims testing this
hypothesis in MPR transporters are to define: (1) the regulatory architectures adopted across transport
cycles, (2) the functional and structural roles of R-domain phosphorylation on catalytic regulation, and (3)
the molecular basis of substrate selection and lipid transport in membrane homeostasis.
This application uses an innovative multidisciplinary approach that applies advances in membrane
protein biochemistry and electron cryo-microscopy to structurally and biophysically undercharacterized
fungal integral membrane proteins. In light of the growing threat of Candida infections, the significance
of our proposal is twofold. First, we will establish a mechanistic framework for understanding the
molecular basis of therapeutic failure driven by important Candida virulence factors and their yeast
homologs. Second, we will establish a foundation useful for developing allosteric therapeutics against
drug-tolerance linked to fungal MRP family transporters, with general applicability to all MRP transporters.

Public health relevance
Project Narrative Rising rates of drug resistance and mortality from fungal infections pose major threats to national health and safety. A major culprit for the increased virulence in pathogens such as Candida albicans, auris, and glabrata is a class of proteins belonging to the MRP family of ABC transporters. This proposal aims to identify the functional and structural determinants of how fungal cells regulated MRP transporters during infection by using hybrid approaches in biochemistry, yeast biology, and cryo-EM to gain invaluable insights into new avenues for preventing drug-resistant infections before they can develop.